Collaborative Pediatric Critical Care Research Network - Clinical Site

PROJECT SUMMARY/ABSTRACT – University of Michigan
Pediatric Critical Care Medicine incorporates a multidisciplinary approach to address the medical needs of the
most fragile population of critically ill and injured children. While current mortality rates at most academic, tertiary
care children’s hospitals are below 5%, certain disease processes, notably sepsis and acute respiratory distress
syndrome which are often accompanied with the presence of multiple organ dysfunction syndrome (MODS),
remain associated with significantly higher mortality rates and utilize substantial health care resources. Despite
this, the occurrences of these most challenging diseases do not occur sufficiently often at any one center to
enable an effective, single-site study that will advance both our understanding and management of these
diseases. Mindful of this reality, the Eunice Kennedy Shriver National Institute of Child Health and Human
Development (NICHD) demonstrated great insight and vision in funding an infrastructure to create a multi-center
research network, the Collaborative Pediatric Critical Care Research Network (CPCCRN). Our Pediatric Critical
Care program at the University of Michigan, and the division Critical Care Medicine at the Children’s Hospital of
Wisconsin and the Medical College of Wisconsin (MCW) who will participate as our ancillary site, have the
infrastructure to allow us to actively participate in a number of multi-site studies. In addition to possessing this
infrastructure, we also believe both sites have a team of investigators who can make important scientific and
leadership contributions to the field. As a result, we are applying to participate within CPCCRN as a Clinical Site
to assist in executing a large clinical trial investigating the efficacy of GM-CSF in critically ill children with sepsis
entitled, Personalized Immunomodulation in Sepsis-induced MODS. We have the infrastructure and intellectual
capacity to contribute in a meaningful way to the on-going growth and success of this research network that is
committed to improving both the short- and long-term outcomes of critically ill and injured children. The goals of
this proposal are for the Division of Pediatric Critical Care Medicine at the University of Michigan and our partner
ancillary site, the Division of Pediatric Critical Care Medicine at the Medical College of Wisconsin to collaborate
fully with the Executive Committee, the Data Coordinating Center and the other CPCCRN sites. In combination
with our partner ancillary site, our site will provide access to over 100 PICU beds with over 4500 annual
admissions, enabling us to participate fully in the “Personalized Immunomodulation in Sepsis-induced MODS”
trial described in the overall component of this application. Our site proposal has three specific aims to achieve
these goals: 1) to actively collaborate in implementation of the Collaborative Pediatric Critical Care Research
Network clinical trial, 2) to provide opportunities for young investigators at the University of Michigan, as well as
the Medical College of Wisconsin, to participate in CPCCRN meetings, committees, or trial implementation with
the goal of developing these promising and talented individuals into fundable clinician scientists, 3) to implement
the Personalized Immunomodulation in Sepsis-induced MODS trial.

Public health relevance
PROJECT NARRATIVE – University of Michigan The incidences of some of the most challenging diseases that contribute to pediatric critical illness, notably acute respiratory distress syndrome and sepsis, are such that relying on any one center to execute a single site study that will advance both our understanding and management of these diseases is ineffective. In order to improve the care of this vulnerable population of critically ill children, the Eunice Kennedy Shriver National Institute of Child Health and Human Development (NICHD) has addressed this by funding an infrastructure for a multicenter research network, the Collaborative Pediatric Critical Care Research Network (CPCCRN) and the accompanying clinical trial examining the efficacy of GM-CSF in children with sepsis entitiled, Personalized Immunomodulation in Sepsis-induced Multiple Organ Dysfunction Syndrome (MODS). This application will position our Pediatric Critical Care Medicine Research Program at the University of Michigan and our ancillary site at the Pediatric Critical Care Division at the Medical College of Wisconsin to actively participate and contribute in this important national network.